Defining Mechanisms of Cognitive Dysfunction in Central Nervous System Autoimmunity

Project Summary
Cumulative evidence indicates neuromyelitis optica (NMO) patients suffer from disabling cognitive
decline (CD) despite effective immune therapies. We must therefore identify modifiable risk and
protective factors to prevent neurologic disability from CD. Indeed, there is high interest among
people living with CD if immune therapy preserves cognitive function. We have shown in our
longitudinal, multi-center study using Montreal Cognitive Assessment (MoCA) that up to a third of
NMO patients suffer CD, independent of clinical relapse. This R21 will evaluate the pathogenic
NMO-IgG as a mediator of CD in NMO. Distinct patterns of CD among NMO patients exist, but
the underlying mechanism is unknown. Others have shown brain atrophy occurs in NMO even in
the absence of cerebral syndromes, while we have linked the NMO-IgG index titers with brain
atrophy, which informed our hypothesis that NMO-IgG is a mediator of CD by targeting the blood-
brain barrier (BBB) astrocytes with resultant gray and white matter dysfunction. Using NMO as an
experimental model of immune-mediated CD, this study will leverage two distinct pre-existing
cohorts with rich clinical and imaging data accompanied by biospecimens. The first is CIRCLES
(Collaborative International Research in Clinical and Longitudinal Experience Study) cohort
comprised of >1000 NMO patients from 2013-2020. This current proposal will link in-depth
cognitive analyses with high-resolution, state-of the-art imaging data and cutting-edge proteomic
blood biomarker studies, while mining over 8 years of follow-up data. The second is a prospective,
ongoing biorepository, Project BIG (Stanford Brain, Immune and Gut Initiative), accessing data
from >100 NMO patients, which will provide additional information on treatment effects on
cognition over time. Specific aims are designed to test the hypothesis that NMO-IgG expression
is directly linked to BBB deficiency and white matter pathology, leading to CD (aim 1), and that
astrocyte damage from the NMO-IgG attack leads to gray matter dysfunction and CD (aim 2).
Detailed data on clinical and socio-demographic modifiers of cognitive function will be accounted
for in all analyses. The immediate impact of this study is to stop subclinical, relapse-independent
progression and enhance productivity and quality of life, eagerly sought by patients living with
NMO. In broader terms, this proposal has a high potential for advancing our understanding of the
pathophysiology of immune-mediated CD and development of therapies targeting neurotoxic
immune responses.

Public health relevance
Project Narrative Patients with neuromyelitis optica (NMO), an immune condition of the central nervous system, suffer from memory loss and cognitive decline (CD). This proposal will study how an auto- antibody, NMO-IgG, damages the brain tissue and causes CD. Studying NMO will help find treatments or cure for CD from immune causes.